Defining neurobiological links between substance use and mental illness

Dr. Janes continued to grow her newly established lab and began data collection at NID-IRP. She focused on staff recruitment and published 2 manuscripts, which are described below.

1. Wanger T, Janes AC, Frederick BF 2023. Spatial variation of changes in test-retest reliability of functional connectivity after global signal regression: the effect of considering hemodynamic delay. Human Brain Mapping

Global signal regression (GSR) is a controversial analysis method, since its removal of signal has been observed to reduce the reliability of functional connectivity estimates. Here, we used test-retest reliability to characterize potential differences in spatial patterns between conventional, static GSR (sGSR) and a novel dynamic form of GSR (dGSR). In contrast with sGSR, dGSR models the global signal at a time delay to correct for blood arrival time. Thus, dGSR accounts for greater variation in global signal, removes blood-flow-related nuisance signal, and leaves higher quality neuronal signal remaining. We used intraclass correlation coefficients (ICCs) to estimate the reliability of functional connectivity in 462 healthy controls from the Human Connectome Project. We tested across two factors: denoising method used (control, sGSR, and dGSR), and interacquisition interval (between days, or within session while varying phase encoding direction). Reliability was estimated regionally to identify topographic patterns for each condition. sGSR and dGSR provided global reductions in reliability compared with the non-GSR control. Test-retest reliability was highest in the frontoparietal and default mode regions, and lowest in sensorimotor cortex for all conditions. dGSR provides more effective denoising in regions where both strategies greatly reduce reliability. Both GSR methods substantially reduced test-retest reliability, which was most evident in brain regions that had low reliability prior to denoising. These findings suggest that reliability of interregional correlation is likely inflated by the global signal, which is thought to primarily reflect dynamic blood flow.

2. Biernacki K, Molokotos E, Han C, Dillon D, Leventhal AM, Janes AC (In Press). Enhanced decision-making in nicotine dependent individuals who abstain: A computational analysis using Hierarchical Drive Diffusion Modeling. Drug and Alcohol Dependence.

Background: Variability in decision-making capacity and reward responsiveness may underlie differences in the ability to abstain from smoking. Computational modeling of choice behavior, as with the Hierarchical Drift Diffusion Model (HDDM), can help dissociate reward responsiveness from underlying components of decision-making. Here we used the HDDM to identify which decision-making or reward-related parameters, extracted from data acquired in a reward processing task, contributed to the ability of people who smoke that are not seeking treatment to abstain from cigarettes during a laboratory task.

Methods: 80 adults who smoke cigarettes completed the Probabilistic Reward Task (PRT) - a signal detection task with a differential reinforcement schedule - following smoking as usual, and the Relapse Analogue Task (RAT) - a task in which participants could earn money for delaying smoking up to 50min - after a period of overnight abstinence. Two cohorts were defined by the RAT; those who waited either 0-min (n=36) or the full 50-min (n=44) before smoking.

Results: PRT signal detection metrics indicated all subjects learned the task contingencies, with no differences in response bias or discriminability between the two groups. However, HDDM analyses indicated faster drift rates in 50-min vs. 0-min waiters.

Conclusions: Relative to those who did not abstain, computational modeling indicated that people who abstained from smoking for 50min showed faster evidence accumulation during reward-based decision-making. These results highlight the importance of decision-making mechanisms to smoking abstinence, and suggest that focusing on the evidence accumulation process may yield new targets for treatment.